Role of MicroRNAs in Kidney Sodium Regulation

Project Summary/Abstract
This proposal will investigate the role of small non‐coding RNAs, termed microRNAs (miRs), in the regulation
of sodium (Na+) transport in the distal kidney nephron. We will investigate the hypothesis that the
mineralocorticoid hormone, aldosterone regulates the expression of specific miR clusters in the distal kidney
nephron cortical collecting duct (CCD). These miRs target mRNAs to alter Na+ transport. Expended up-
regulation of the aldosterone-induced miRs then feedback to reduce the aldosterone response (negative
feedback regulation). We propose to test this novel role of miRs in Na+ homeostasis but using a miR cluster
KO mouse line. The miR-17~92 cluster will be deleted from the kidney nephron using a conditional, inducible
KO line and the impact on long-term aldosterone signaling will be investigated. In the second part of the
proposal, the mechanism the aldosterone-regulated miRs use to alter Na+ transport will be investigated in
primary kidney cells.

Public health relevance
Project Narrative This proposal will investigate the role of small non‐coding RNAs, termed microRNAs, in the regulation of sodium (Na+) transport in the distal kidney nephron. We will investigate the hypothesis that the mineralocorticoid hormone, aldosterone up-regulates the expression of specific miR clusters in the distal kidney nephron which feedback to negatively alter Na+ transport. We will test this novel function of microRNAs in Na+ homeostasis using control mice and a nephron-specific microRNA knockout mouse model that will be subjected to aldosterone stimulation and changes to renal Na+ handling will confirm that these microRNAs are acting as a negative feedback regulators of aldosterone signaling.